Pilot/Exploratory Studies Core (PESC)

SUMMARY The goal of the University of Florida (UF) Older Americans Independence Center (OAIC) Pilot and Exploratory Studies Core (PESC) is to help plan future independently supported studies that address the UF OAIC's overall research theme of mobility and prevention of disability in older Americans. To this end, the PESC solicits and selects promising innovative pilot, exploratory, and developmental studies and secure optimal infrastructure, environment, funding, expertise, and resources. Core leaders monitor study progress, help analyze and interpret results, and provide guidance in translating these pilot data into high-quality and original research study proposals that successfully compete for independent extramural funding. The provision of funds for pilot, exploratory, and developmental studies supports Junior Scholars in their efforts to develop research careers in aging. The PESC also allows accomplished investigators in aging to gather data that extend and broaden their focus. In this capacity, it encourages and facilitates experienced investigators traditionally working in other research fields, such as physiology, cancer, pain, sepsis, and cognitive function, to expand their research to include aging. This widens the pool of talent that we believe will contribute to advances in disability prevention through averting mobility loss. In this application we propose four pilot studies and one exploratory study that offer a wide variety of interdisciplinary approaches to address the OAIC research theme. As we have proven over the past several years, we are highly successful in translating findings from our pilot, exploratory, and development studies into extramurally funded grants (76% success rate), and also in supporting our Junior Scholars through the tenure and promotion process.